Mechanisms of differential responses to whole cell and acellular pertussis vaccination

PROJECT SUMMARY
Overall Component
Vaccines are one of the most cost effective and extraordinarily successful medical interventions. Most of those
vaccines depend on CD4 T+ cells and their help to B cells. Our understanding of in vivo, specific human CD4+ T
cell responses to pathogens remains hazy, due to the complexity of the biology, the rarity of the cells, relatively
inaccessible tissue localization, and technical challenges of identifying specific CD4+ T cells. Therefore, our
approach to this serious problem has been to develop multiple new techniques to study human CD4+ T cells
over the past several years. While CD4+ T cell-dependent antibody responses have been the source of protection
for most licensed vaccines (Project 1), there is a very good argument to be made that many of the diseases for
which we do not have successful vaccines require adaptive immune responses beyond antibodies for protection
(Projects 2 and 3). The three Projects proposed here vigorously pursue an understanding of the mechanisms
regulating human anti-pathogen CD4+ T cells, linked by new experimental approaches.

Public health relevance
PROJECT NARRATIVE Overall Component Our understanding of in vivo, antigen-specific human CD4+ T cell responses to pathogens remains hazy, due to the complexity of the biology, the rarity of the cells, and technical challenges of identifying antigen-specific CD4+ T cells, since they can be so heterogeneous in phenotype and cytokine potential. The overall, innovative, technological themes of all three Projects in this CCHI proposal are (1) Studying human antigen-specific CD4+ T cells using novel, highly sensitive live cell techniques in a cytokine-agnostic manner; (2) Utilization of single- cell RNA-seq for in-depth characterization of antigen-specific CD4+ T cell and B cell biology, heterogeneity and TCR/BCR repertoire; and (3) Direct analysis of CD4+ T cells and germinal centers in lymphoid tissues via fine needle aspirates and whole lymph node and tonsil biopsies. Each of these are used heavily in Project 1 (Crotty), Project 2 (Sette), and Project 3 (Vijayanand), such that the three Projects proposed here vigorously pursue an understanding of human anti-pathogen CD4+ T cells, linked by new experimental approaches and novel preliminary findings regarding CD4 T cell biology.